Racial/Ethnic Disparities in Medicare Advantage vs. Traditional Medicare: Evidence to Improve Equity in Medicare

PROJECT SUMMARY / ABSTRACT
In April 2023, states began to unwind provisions of the COVID-19 public health emergency that enabled people
to remain continuously enrolled in Medicaid without completing periodic eligibility redeterminations. States are
now required to re-evaluate eligibility for all Medicaid beneficiaries within 14 months. This change is beginning
to affect 12.2 million low-income older adults and disabled individuals with Medicare and Medicaid, known as
dual eligibles, who rely on Medicaid supplemental insurance for help paying Medicare premiums, cost sharing,
and for some, services such as dental and long-term care. To maintain Medicaid coverage, older adult duals
need to complete a complex redetermination process, accounting for programs with distinct eligibility rules,
each of which requires detailed proof of income and assets. The complexity of the redetermination process
raises concerns that older adults may experience abrupt changes in Medicaid or lose this coverage altogether.
Prior studies, including those by our team, highlight the potential for loss of Medicaid supplemental insurance
and variation in its effects according to individuals’ Medicare coverage (e.g., Medicare Advantage vs.
traditional Medicare), health diagnoses (e.g., Alzheimer’s disease), and race/ethnicity. The extent of Medicaid
loss may also vary based on state policies that simplify or automate Medicaid redeterminations. In this
supplement to NIA grant R01AG076437, we propose to leverage national Medicare administrative data (which
reports monthly Medicaid enrollment) and a soon-to-be-fielded survey under our parent R01 to examine
individual-, Medicare plan- and policy-level determinants of Medicaid loss among older adults, assess older
adults’ experiences with redeterminations, and identify racial and ethnic disparities in these outcomes. We will
also examine the effects of Medicaid loss on health care use and disparities, focusing on outpatient visits and
medication filling (sensitive to cost sharing in Medicare) and preventable hospitalizations (which may reflect
adverse health outcomes). This supplement builds on our parent R01, which examines racial and ethnic health
care disparities among older adults in Medicare Advantage vs. traditional Medicare, in three ways. First, we
examine how changes in Medicaid coverage moderate racial and ethnic health care disparities among older
adult Medicare beneficiaries. Second, we examine the role of factors at Medicare plan and state policy levels in
mitigating Medicaid coverage loss and its effects on health care use and disparities. Third, we capitalize on a
planned survey of Medicare beneficiaries for our parent R01, and include an additional sample of low-income
older adults, to assess self-reported experiences navigating Medicaid redeterminations. By providing timely
evidence about the effects of Medicaid redeterminations on low-income older adults, our research can guide
future reforms to improve the continuity of Medicaid supplemental coverage and promote equitable care for
low-income older adult Medicare beneficiaries.

Public health relevance
PROJECT NARRATIVE Beginning April 1, 2023, 12.2 million low-income older adults and disabled individuals with Medicare and Medicaid (dual eligibles) face potential interruptions in, or termination of, Medicaid coverage as they undergo Medicaid eligibility redeterminations for the first time in three years. This supplement to R01AG076437 will examine Medicaid coverage loss and its consequences among low-income older adults, including differential experiences and consequences of Medicaid redetermination and coverage loss by whether individuals have Medicare Advantage vs. traditional Medicare enrollment or full vs. partial Medicaid, state policies, and older adults’ race, ethnicity, and health diagnoses. Findings from this work will elucidate potential changes in Medicaid policy to improve coverage continuity and promote equitable access to care among low-income older adults who rely on Medicaid for supplemental health insurance.